National Center for Construction Safety and Health Research and Translation

Project Summary/Abstract: The objective of our Center is to conduct research that leads to
the reduction of injuries and illnesses and improves worker well-being at a national scale in the
U.S. construction industry. The Center will (1) respond to NORA 3 Construction sector priorities,
NIOSH strategic goals, and the 2018 NIOSH Construction Expert Panel review; (2) grow our
leadership role on r2p by strengthening the r2p capacity of the overall Center, NIOSH
investigators, and others outside our consortium while contributing to the greater body of
translation research; (3) track and uncover policies, programs, and practices in the industry and
give the public up-to-date visual access to data and statistics; (4) respond to technical
assistance requests; (5) serve as a national repository and resource for construction safety,
health, and well-being information and actionable products; (6) build on our research knowledge
base to accelerate the adoption of good practices; (7) act quickly and decisively to emerging
issues and threats; and (8) maximize impact through our comprehensive evaluation plan. The
Centers's specific aims are:
Specific Aim 1: Manage the Center through the five functional cores and nine research
projects.
• Through the PAE Core, administer a multi-disciplinary, fully integrated, and synergistic
Center that fosters the continued advancement of construction safety and health
research and facilitates effective ties between investigators and industry, including
contractors, workers and their representatives, regulators, insurers, users and other
industry partners, and continuously assess those efforts through a comprehensive
evaluation plan that focuses on both process and outcomes.
• Through the Applied Research Core, which is comprised of nine research projects, test
and evaluate risk reduction strategies that prevent injuries and illnesses.
• Through the r2p Core, coordinate and promote translation research to speed up the
adoption of best practices, evaluate impact of diffusion and continuous improvement of
diffusion strategies and tactics, and identify and overcome barriers to the diffusion and
adoption of best practices.
• Through the Data Core, track changes in industry characteristics, safety and health
practices, and occupational injury and illness outcomes, and provide support services for
construction industry data and statistics for all industry stakeholders, particularly the
NORA Construction Sector Council and NIOSH Construction Program, to track progress
in achieving NORA and NIOSH research priorities.
• Through the COE Core, continuously explore new ways in which to reach construction
industry stakeholders, particularly those that represent small industry employers; assess
communications channels to identify those most effective in reaching targeted
construction industry populations, such as workers, contractors, and owners; maintain
and continuously update a repository of evidenced-based best practices to prevent
hazards; and promote the adoption of those practices through an expansive
dissemination plan, including social media, targeted mailings, webinars, workshops, and
electronic communications.
Specific Aim 2: Use outputs from the Center's cores and projects to facilitate and measure
outcomes across the U.S. construction industry. The Center will deliver a multi-disciplinary, fully
integrated, and fully functional national program to foster the continued advancement of
research and facilitate ties between investigators and construction industry stakeholders.

Public health relevance
Project Narrative: The Overall National Construction Center (Center) is comprised of the Planning, Administration and Evaluation (PAE) Core, which manages and coordinates all Center research projects and activities, and four operating cores, Data Core, r2p Core, Communications (COE) Core and Applied Research Core. Each of these core functions, in addition to the nine research projects housed within the Applied Research Core, respond to NORA 3 Construction Sector priorities, NIOSH strategic goals, and the 2018 NIOSH Construction Expert Panel Review. All findings from these projects and activities will be shared broadly through our extensive network of industry partnerships and outreach channels housed within the r2p Core and COE Core.